IL17 dependent angiocrine signaling drives inflammation in alcohol associated hepatitis

Project Abstract
Alcoholic hepatitis (AH) is characterized by intense liver inflammation and injury in the setting of excess alcohol
ingestion. Cytokine and chemokine upregulation leads to immune cell infiltration and drives inflammation in AH.
Liver sinusoidal endothelial cells (LSEC) are an important source of chemokine expression in the liver and
participate in paracrine signaling to attract immune cells in a process termed “angiocrine signaling”. Pathway
analysis of AH liver RNA-sequencing suggests a potential role of IL17 in mediating LSEC angiocrine signaling.
IL17 is a cytokine involved in many autoimmune and inflammatory disorders. Our preliminary data shows that
IL17 synergically stimulates CXCL chemokine production with TNFα, but the underlying mechanism is not clear.
The regulation of IL17 production from T cells also requires further study. To test our hypothesis, we will employ
complementary cell biologic and in vivo approaches to study the following specific aims: Aim 1. LSECs enhance
CXCL1-dependent neutrophil transendothelial migration in response to IL17; Aim 2. Therapeutic
targeting of a super enhancer in T cells downregulates IL17 and ameliorates inflammation in AH.
This supplement will provide additional support for personnel hiring and training to further the work proposed in
Aim 1 during my upcoming leave of absence. In Aim 1, we explored the role of IκB𝜁𝜁, a transcription factor
previously implicated in IL17 signaling, in mediating the interaction between IL17 and TNFα signaling pathways.
We are planning to generate LSEC-specific IκB𝜁𝜁 KO mice and test the effect of IκB𝜁𝜁 deletion in AH model. In
addition, we will use an anti-IL17 antibody to observe the effect of IL17 axis inhibition in AH model. We plan to
isolate LSECs from control and treated mice and submit these samples for bulk RNA-sequencing analysis. Better
understanding of the IL17 mediated angiocrine signaling process may reveal novel therapeutic targets for
treatment of AH. Therefore, our overall aims and approaches are aligned with the mission of NIAAA to further
understanding and treatment of alcohol-associated liver diseases.

Public health relevance
Project Narrative Alcoholic hepatitis is a disease of intense liver inflammation and injury caused by heavy alcohol use that can be deadly when severe. Cytokine IL17 may contribute to the development of alcoholic hepatitis by stimulating liver sinusoidal endothelial cells (LSECs) to produce chemokines that drives the inflammatory response. In this study, we will explore the mechanisms of IL17-mediated LSEC activation in alcoholic hepatitis and experiment with novel ways of inhibiting IL17 production by targeting a gene regulatory element.